CASI-Plus: A mHealth Tool for Client Engagement to Improve Ukraine's Assisted Partner Services (APS) Program Workflow and HIV Testing Outcomes

Project Abstract
Assisted partner notification services (APS) involves public health contract tracing for clients with
HIV or other sexually transmitted infections, in order to confidentially notify contacts of their
exposure and link them to testing and treatment services. Through several randomized controlled
trials (RCTs), APS has been demonstrated as a cost-effective strategy for increasing HIV testing
and case identification. Some APS programs implemented at scale in low- and middle-income
countries have fallen short of optimal outcomes, because APS participants typically only name
their current sex partner or fail to notify their partners. Finding innovative ways to increase the
number of partners elicited and the number completing HIV testing is critical to success in scale-
up. In Ukraine, HIV prevalence is estimated at 1% among adults, 7.5% among men who have sex
with men (MSM), and 22.6% among persons who inject drugs (PWID). There is a substantial
undiagnosed fraction of people living with HIV, estimated at 25% overall, 41% among MSM, and
42% among PWID. Ukraine scaled up APS in 40 public-sector health facilities in 2019-21;
however, the contact index (number of partner contacts named per index client) was only 1.14 for
sexual and needle-sharing partners, and 23.3% of partners with unknown status did not complete
The CASI-Plus mHealth tool leverages computer-assisted self-interviews (CASI) in 2
steps: 1) an initial contact elicitation interview designed to reduce social desirability bias
associated with reporting multiple sexual partners, same-sex sexual partners, or needle-sharing
partners; and 2) repeated client follow-up surveys and health worker engagement prompts to
facilitate communication and case management through the partner notification and testing
process. conduct formative research from health worker
and client perspectives to design the CASI-Plus mHealth intervention
assess adoption of CASI-Plus and its impact on contact elicitation CASI-Plus
assess appropriateness and feasibility
of the CASI-Plus intervention and its impact on overall acceptability of APS services.
testing.
The study’s specific aims are to: 1) (R21)
; and 2) (R21) in a pilot-level
RCT, ; 3) (R33) test
on the HIV testing index in an expanded RCT; and 4) (R33)
The research
team includes experts in APS programs, digital health development, usability assessment, and
mixed methods health services research from the University of Washington and the Ukraine
Ministry of Health’s Public Health Center. This partnership offers great potential to integrate the
mHealth solution into the national health information system and translate research findings into
policy and practice, should acceptability, appropriateness, feasibility and effectiveness be strong.

Public health relevance
Public Health Relevance This research study seeks to develop and test a mHealth intervention for optimizing HIV testing and HIV case finding outcomes within assisted partner notification services (APS) programs, so that groups at highest risk for HIV can be linked to HIV treatment and prevention services. The CASI-Plus intervention seeks to improve the contact elicitation stage of APS services by reducing social desirability bias associated with reporting sexual and needle-sharing partners, and to improve completion of partner notification and testing by facilitating case management and client engagement. This study will provide evidence on the usability, acceptability, appropriateness, feasibility and effectiveness of integrating CASI-Plus in the APS workflow.